Improving extraction success of FFPE samples with automated and reliable microfluidic sample preparation

Project Summary/Abstract
SBIR Phase II Award Number: 2R44GM148126-02A1
Award Title: Improving extraction success of FFPE samples with automated and reliable
microfluidic sample preparation
Redbud Labs is requesting TABA supplemental funding to support commercialization
planning for its SBIR Phase II project focused on automated extraction of nucleic acids
from FFPE tissue samples. The proposed activities include external market research,
voice-of-customer interviews, competitive landscape analysis, and development of
strategic messaging and commercialization collateral. These efforts will help validate
market demand, inform go-to-market strategy, and accelerate adoption of Redbud’s
microfluidic FFPE platform. The work will be performed by i5 BioPartners and
complements the technical R&D supported under the parent award.

Public health relevance
Project Narrative SBIR Phase II Award Number: 2R44GM148126-02A1 Award Title: Improving extraction success of FFPE samples with automated and reliable microfluidic sample preparation This project aims to accelerate the commercialization of Redbud Labs’ microfluidic platform for automated extraction of nucleic acids from FFPE tissue samples. The proposed TABA-funded activities will address key barriers to adoption by engaging with industry experts and end-users to validate market needs and optimize product messaging and positioning. By supporting external market research, strategic communication development, and outreach collateral, this initiative will enhance the project's impact by facilitating real- world implementation of a technology that improves reliability, reproducibility, and throughput in sample preparation. These improvements support NIH’s mission to advance biomedical research and health through innovation and effective translation.